TRP Channels and Air Pollution

Project Summary/Abstract:
Breathing unhealthy amounts of particulate matter (PM) in polluted air is unavoidable for many people. Currently,
our knowledge of specific biochemical interactions that link exposure to the many adverse health effects of PM
is incomplete, as is our ability to directly treat and/or prevent these effects. In this study we will build upon our
work establishing a novel mechanistic paradigm for how PM can cause deleterious effects in the lungs, involving
activation of the transient receptor potential ankyrin-1 (TRPA1), melastatin-8 (TRPM8) and vanilloid-1 (TRPV1)
ion channels. Our work shows that different types of PM activate different TRP channels, often leading to specific
effects that are relevant to human respiratory disease causation and acute exacerbation. Thus, a continued in-
depth assessment of this mechanistic paradigm has the potential to provide crucial knowledge for understanding
the basis for respiratory malaise associated with PM, and to further our understanding of the precise contributions
of TRP channels to environmentally-sensitive lung diseases such as asthma. Additionally, by establishing
fundamental mechanisms that regulate pathophysiological outcomes associated with TRP channel activation by
PM, our research could reveal innovative strategies for developing interventions to possibly treat and/or prevent
environmental lung diseases.
The current studies are motivated by results showing that differential activation of TRPA1, M8, and V1 in human
lung cells by PM is coupled to pro-inflammatory and other responses that affect human respiratory disease-
related pathways and phenotypes, generally referred to herein as “PM toxicity.” Further, there are species-
specific differences in TRP channel responses to PM, suggesting that rodents may not adequately model TRP-
dependent mechanisms of PM toxicity in humans. We opine this could be an important barrier for translating
mechanistic findings from rodent models to humans, and for developing effective interventions. Finally, we have
found that TRPA1, M8, and V1 single-nucleotide polymorphisms (SNPs) can modulate cellular responses to
certain forms of PM, as well as ostensibly cause poorer asthma symptom control in children. Also, the TRPV1
I585I/V SNP genotype correlates with the diagnosis and severity of asthma and chronic rhinosinusitis (CRS).
Thus, assessment of mechanisms by which selected TRP SNPs affect cellular responses to PM, as well as
asthma control, could reveal prognostic biomarkers of hypersensitivity to PM, and criteria for personalizing
medical care. Our hypothesis is: Activation of TRPA1, M8 and/or V1 by PM represents a pivotal event underlying
the toxic effects of PM. The specific aims are to: 1) Determine mechanisms and the significance of species-
specific TRP channel activation by PM; 2) Elucidate the basis and toxicological significance of TRPV1 I585I/V-
dependent TRPA1 expression by human lung epithelial cells; and 3) Quantify the impact of TRPA1, M8, and V1
genetics in environmental exacerbation of asthma.

Public health relevance
Project Narrative: Human-generated and natural-source particulate air pollutants (i.e., PM2.5-10) in the air we breathe are a health risk. Our research is focused on discovering how different forms of environmental PM adversely affect the lungs and human health. Ultimately, we hope to use our findings to create solutions for improving human health.